Defining the landscape of structural alterations in African American Multiple Myeloma

Summary
Multiple Myeloma is a malignancy of long-lived plasma cells of the bone marrow and is the second most common
hematologic malignancy, with over 34,000 new cases and nearly 13,000 deaths expected in the US in 2021.
However, amongst African Americans, myeloma is the most common hematologic malignancy with the incidents
rate between 2-3 times higher than that observed in Caucasians. Consistent with this finding, the precursor to
myeloma, Monoclonal Gammopathy of Undetermined Significance (MGUS) is also observed at a higher
frequency in African Americans. Thus, the increased frequency of myeloma is likely to due to underlying factors
that result in both the development of MGUS as well as its progression to myeloma. Translocations that
juxtapose oncogenes to the potent enhancers of the immunoglobulin heavy chain (IgH) or trisomies of odd-
numbered chromosomes (hyperdiploidy) are the initiating events in nearly all myelomas. However, these are
rarely sufficient to cause myeloma, which almost always have additional copy number alterations (e.g., del17p,
amp1q21) and/or mutations (e.g. KRAS, TP53) observed at diagnosis and these influence outcome.
Interestingly African Americans tend to have genomic alterations that would predict a superior outcome, however
we have found that in patients treated identically with the current standard of care at our institution, there is no
difference in the patient outcomes. Additionally, in the MMRF CoMMpass study, African Americans do worse
than Caucasians despite no difference in the treatment and being diagnosed at a significantly earlier age, which
is typically considered a good prognostic marker. Together these data suggest that our current approaches are
either not accurately predicting risk or our therapeutic approaches are not optimized for the African American
population. Our recent finding suggest that these events could be related. Utilizing whole genome sequencing
that is part of the MMRF CoMMpass study, we performed an analysis of the structural landscape of newly
diagnosed multiple myeloma. We found that patients that have translocations in the immunoglobulin lambda
light chain locus (IgL) have a significantly worse outcome than other patients in the study. IgL translocations
were found in 10% of the population and 70% were associated with hyperdiploid myeloma, a good prognostic
marker routinely tested for clinically whereas IgL events are not. Thus, these patients were misdiagnosed with
lower risk disease. We also demonstrated that the likely cause of misdiagnosis was resistance to one of the
backbone myeloma drugs, lenalidomide. African American patients with IgL translocations experienced strikingly
worse outcomes than their European American counterparts. Based on these findings we hypothesize that there
are additional structural events that are not routinely tested for which can influence outcomes and that these
may differ in African American myeloma. These events may also contribute to the early onset of disease. We
propose two Specific Aims to test this hypothesis as well as the development of a test to detect these changes.

Public health relevance
Relevance African Americans have a higher incidence of multiple myeloma and based on currently tested genetic alterations would be expected to have a lower risk disease than Caucasians, however even when treated in a similar fashion, African American patients do no better or even worse than Caucasians. We will test the hypothesis that genomic differences exist in African American myeloma that are currently not used as part of standard diagnosis and these differences correspond to outcomes that are poorer than expected in this population. A more comprehensive characterization of the genomic landscape of myeloma in African Americans should lead to better understanding of the differences in the development of disease as well as improved treatment approaches and superior outcomes.